Targeting and imaging of inflammatory circuits in CLAD

PROJECT SUMMARY / ABSTRACT
Lung recipients suffer from shorter life spans and higher rejection rates when compared to other solid organ
recipients. A major impediment to long-term lung transplant survival is chronic allograft dysfunction (CLAD).
This fibrotic disease causes the progressive loss of pulmonary function for which there is no effective medical
treatment. Based on outcomes studies that show club cell dysfunction and injury are linked to CLAD, we have
developed a new mouse orthotopic lung transplant model that develops CLAD by recapitulating this clinically
observed relationship. Using this innovative model, we have recently reported that classical monocyte (CM)
differentiation into monocyte-derived alveolar macrophages results in the activation of tissue-resident memory
CD8+ T cell activation (CD8+Trm) to injure bronchial epithelium and promote CLAD. We have also shown that
we can image CLAD development using CCR2 molecular probe-based positron emission tomography (PET)
imaging. Although CM and CD8+Trm activation is required for CLAD development, the pathways that regulate
their local activation remain poorly described. New data from our lab show CM utilize different metabolic
programs to facilitate graft infiltration and promote fate determination. We have also developed nanoparticle
formulations to deliver metabolic inhibitors specifically to CM during CLAD pathogenesis. Finally, by identifying
a novel receptor for club cell secretory protein (CCSP), we have generated pilot data that indicates club cells
directly regulate CD8+Trm activation. Based on this new evidence, we propose to test whether (Aim 1) targeting
metabolic adaption of CM and (Aim 2) recombinant human CCSP replacement therapy prevents CLAD through
inhibiting CD8+Tm activation. Finally, in Aim 3, we propose to examine whether CCR2 molecular probe-based
PET imaging can detect CLAD in human lung recipients. The overall goal of this project is to provide the basis
to develop new CLAD prevention and detection strategies by uncovering immunological mechanisms that
mediate CLAD pathogenesis.